Leadership and Administrative Core

SUMMARY
The Leadership and Administrative Core (LAC) is responsible for strategic planning, organization,
administrative operations, and evaluation of the Older Americans Independence Center (OAIC) research and
training program. A special effort is devoted to ensure the cohesion of the Center and maintain an
interdisciplinary and translational research focus on the common research theme, which is “promotion of
mobility and independence.”
The key LAC tasks are achieved by the Core Leadership and four committees. The Executive Committee,
which is composed of the OAIC Core leaders, administers, governs, provides scientific guidance, and sets
productivity benchmarks for the OAIC. The External Advisory Board, which is composed of experts external to
the institution, reviews all OAIC activities and provides overall scientific guidance to the OAIC. The newly
established Community Advisory Board, which advises regarding community outreach and the overall OAIC
focus The Independent Review Panel, which is composed of ad hoc experts (at least one third external to the
institution), reviews the proposed support for development projects, and pilot/exploratory studies for funding
consideration. Taken together, the LAC provides support for planning, organizational, evaluation, and
administrative activities relating to the other Cores and to the OAIC as a whole. The LAC monitors, stimulates,
sustains, evaluates, and reports progress toward the overall goals of the OAIC.